Administrative and Biostatistics Core

ABSTRACT (Core A-Administrative and Biostatistics Core)
This application seeks support for its efforts to discover, apply, and translate scientific knowledge about
pancreatic cancer to improve public health by reducing the burden of this disease. The Administrative and
Statistics Core will coordinate, allocate and oversee resources and provide oversight to ensure the
smooth operation of the Projects and shared resource Cores comprising this program project.
Coordination of these activities will be facilitated through the maintenance and curation of a program
website by this Core. Core personnel include the Lead (Director), the co-Lead (Co-Director), a Program
Manager, a biostatistician, and a Financial Administrator. The Director assumes responsibility for the
scientific and educational directions of the program. The Co-Director will assist the Director in the
operation of the program and will assume full responsibility when the Director is not present. The roles of
other Core personnel are detailed below. This Core is responsible for: 1) oversight and allocation of
center resources to each Project (three in this program), 2) oversight and allocation of Research Core
resources, 3) coordinating interactions within the P01 and with the relevant community of science through
the program website, and 4) coordinating statistical support for the Projects.

Public health relevance
Project Narrative (Core A) This P01 application from investigators at Stanford University seeks to discover, apply and translate science about pancreatic cancer (PDAC), with the ultimate goal of improving care for patients with this disease. To address fundamental, persistent questions about the biology of PDAC, we have assembled a superb, interactive team of productive collaborators to lead our Projects and Research Cores. This team will identify genetic and immune cell-based interactions and pathways that regulate the inception and progression of PDAC. Advances from studies proposed here could broadly impact pancreas cancer biology, and drive translational efforts in PDAC.